A system to enhance prevention of diabetic foot ulcers and their recurrence

Project Summary/Abstract
Problem The prevalence of diabetes mellitus in the U.S. is high and increasing in both adults and children—over
1.5 million Americans are diagnosed with diabetes annually. Among the consequences of diabetes, diabetic
foot ulcers (DFUs) are a common and major complication, resulting in lower quality-of-life, hospitalization,
disability, amputation, and even death. DFUs are the leading cause of hospitalization and disability in patients
with diabetes, and are the largest category of excess medical costs associated with diabetes. In light of the
impending diabetes epidemic and the high prevalence and grave consequences of DFUs, the need for improved
prevention of DFUs and their recurrence is clear.
The major risk factors for DFUs include diabetic peripheral neuropathy, peripheral arterial disease (PAD),
higher pressure on plantar surfaces, and an unsteady gait. DFUs can arise from acute trauma or from recurrent
weight-bearing activity that is undetectable by the patient due to insensate feet. Research suggests that active
management of foot health can prevent the occurrence and reoccurrence of a DFU; however, approaches must
be multifaceted and require continual monitoring from both patients and caregivers.
Solution The SoleSaver system is a sensor-enabled, unobtrusive, and non-binding foot-worn garment similar
to a sock that can be used to continually monitor multiple facets of foot health in order to maximize DFU
prevention and minimize DFU recurrence. SoleSaver measures both the pressure and temperature across the
plantar surface, tracks gait indices, and provides an index for PAD status and changes thereto. SoleSaver also
measures adherence to use of offloading or other prescribed footwear. SoleSaver collects data continuously and
relays measurements wirelessly to a portable computing device (e.g., a smartphone). A specialized software
application automatically generates interpretive reports for clinicians, sends reminders, and delivers timely alerts
and warnings to the patient. Compiled data and results are also offloaded to a secure, cloud-based provider
dashboard. The provider dashboard enables caregivers to securely and remotely review patient data and provide
clinical feedback and advice (e.g., “we need to adjust your offloading footwear”) without the need for burdensome
and costly office visits that only provide a snapshot picture of the patient’s foot health. The SoleSaver software
automatically generates clear, concise reports that include summary data to simplify interpretation by clinicians.
SoleSaver fulfills the need for an ergonomic, accurate, reliable, and low-cost DFU prevention system for use in
healthcare and clinical research.
The proposed Phase I SBIR effort will demonstrate proof-of-concept and feasibility for the SoleSaver method-
ology via rigorous evaluation of a Phase I prototype on patients with diabetes and age- and sex-matched healthy
participants.

Public health relevance
Project Narrative Products resulting from this grant will provide a multifaceted management/early warning system for preventing diabetic foot ulcers and their recurrence. SoleSaver sensor data, measured continuously in the patient’s free- living environment, will be used to: (1) identify early potential formation of a DFU to enable prompt and timely intervention (e.g., offloading); (2) quantify gait abnormalities and changes to gait that could result in a DFU; (3) ascertain peripheral arterial disease (PAD) status and changes thereto over time; (4) determine patterns of adherence to prescribed footwear; (5) quantify shear pressure in different areas of the plantar surface (both high impulse pressure and lower cumulative pressures) to issue alerts and enable expeditious offloading; (6) facilitate fabrication of custom footwear and; (7) assist in evaluating the effectiveness of custom footwear and other interventions in reducing plantar stresses and the formation of DFU. Additionally, SoleSaver can be used in clinical trials and other research to better understand the conditions that lead to DFU and the effect of new treatments.